Neuropathology Core

Alzheimer’s disease (AD) is a multifactorial and complex disease and includes the impact of the
cerebrovascular system on the induction and progression of the dementia. Correlation of
experimental findings in disease models with the changes in the human CNS can now be
approached with cellular, molecular and genetically related molecular markers. System
connectivity is now approached three-dimensionally using novel methods of cellular labeling of
animal model or human tissues combined with imaging, as seen with CLARITY-based
preparations viewed with two-photon or lightsheet imaging. In AIM 1 the Neuropathology Core
serves these functions by providing at autopsy, CNS tissues for accurate diagnoses of AD and
accompanying pathologies. AIM 2 provides individual and multiple investigators with diseased
tissues, blood, blood products and CSF for research. Contribution to a common database in
AIM 3 serves to correlate neurological, psychometric, neuroimaging and behavioral data with
the neuropathological and molecular findings. It also coordinates contribution of tissues, blood
and cerebrospinal fluid (CSF) to national initiatives that also define genomic data, such as ApoE
and other risk factors, and biomarker information addressed in AIMS 4-6, that highlight those
functional in the neurovascular unit and in the blood-brain-barrier, and the recently described
“glymph” system. In AIM 7, training and education of neuropathologists, neurologists, and
neuroscientists bring AD and related dementia further into focus by defining the potential
translational approaches leading to novel therapies.